Pathological SUR1-TRPM4 Expression in Neurons Heightens Chronic Seizure Susceptibility

Project Summary/Abstract
Current anti-seizure medications are insufficient for managing seizures in epilepsy patients, as they become less
effective over time and are associated with significant side effects. One promising molecular target for reducing
seizures is the SUR1-TRPM4 channel. This channel is a sodium conducting ion channel not significantly
expressed in healthy brain that upregulates de novo in neurons in other seizure-related disease pathologies such
as stroke and traumatic brain injury. SUR1-TRPM4 upregulation is a disease-specific pathologic mechanism that
has been successfully targeted and shown to be effective in reducing stroke pathology through preclinical studies
and clinical trials. Preliminary data demonstrate that SUR1-TRPM4 expression increases in neurons in epileptic
tissues resected from patients and in a pentylenetetrazol (PTZ) kindling rodent model of epilepsy. Furthermore,
pharmacological inhibition of SUR1-TRPM4 in vitro prevents neuronal population hyperactivity induced by low
Mg2+, and inhibiting SUR1-TRPM4 in vivo using pharmacologic inhibitors (glyburide, 9-phenanthrol) or genetic
knock-out (KO) globally or specifically in neurons attenuates the development of seizures induced by PTZ
kindling. This proposal aims to define the contributions of neuronal SUR1-TRPM4 expression to chronic seizure
activity by assessing the effects of neuron-specific SUR1-TRPM4 overexpression on neuronal hyperexcitability
in vitro and seizure susceptibility in vivo. This proposal fits the NINDS mission of reducing neurologic disease
burden, has rapid translatable potential due to the SUR1 inhibitor glyburide being FDA approved, and could
improve current anti-seizure medications by identifying a new epilepsy-specific therapeutic target not significantly
expressed in healthy brain tissue. This research will be conducted across two labs with specific expertise in the
SUR1-TRPM4 channel and epilepsy at a state-of-the-art institution in the University of Maryland School of
Medicine. I will gain valuable experience in molecular and electrophysiologic techniques, particularly for inducing
protein overexpression and data collection and analysis of neuronal firing via calcium imaging and
electroencephalogram (EEG). Toward that end, this project will continue my development towards my ultimate
career goal of becoming an independently funded neurosurgeon-scientist focused on translational and clinical
research in epilepsy.

Public health relevance
Project Narrative Despite the high prevalence of epilepsy in the United States, current anti-seizure medications are limited because a significant proportion of patients develop drug resistance and experience significant off-target side effects. This proposal will determine whether pathological neuronal expression of the SUR1-TRPM4 channel, a potential disease-specific therapeutic target I’ve previously found to upregulate in epileptic human and rodent brain, contributes to elevated seizure susceptibility in chronic epilepsy. Direct inhibition of SUR1-TRPM4 has high therapeutic potential, especially with the availability of an FDA-approved inhibitor glyburide, as an effective mechanism for seizure reduction in patients with epilepsy and other pathologies associated with seizures in which neuronal SUR1-TRPM4 expression has been characterized such as stroke, traumatic brain injury, neonatal hypoxia, and intracranial hemorrhage.